CLINTRUSC Admin Core

ADMINISTRATIVE CORE: PROJECT SUMMARY
The Administrative Core (AC) of the Center for Clinical & Translational Research at the University of South
Carolina (CLINTRUSC) aims to improve incidence, survival, and mortality of preventable diseases, including
type 2 diabetes mellitus (T2DM) and its precursor conditions, cardiovascular disease, cancer,
neurodegenerative, and infectious diseases. We have documented disparities in African Americans and other
socioeconomically marginalized and medically underserved individuals in our region and have made some
progress in reducing disease incidence and improving survival.1-20 However, much more needs to be done.
Over several decades we have discerned that the major impediment to making additional progress concerns
our inability to create a cadre of physician scientists and other healthcare providers committed to serving in our
community who can conduct community-relevant research, including both primary, mechanism-focused studies
and dissemination and implementation science. As described in the Overall, we have many of the pieces
necessary to create a high-impact clinical and translational (C&T) research program that will benefit our most
vulnerable citizens. These assets include core resources developed by other IDeA programs, including INBRE
and COBRE. They also include structures and programs developed within the Arnold School of Public Health,
School of Medicine, Colleges of Pharmacy and Nursing and other units within the University of South Carolina
that can be used to support broad-based efforts at creating a cadre of physician scientists and conducting
population-relevant research.
The AC is committed to concentrating effective action undertaken through the CLINTRUSC Cores to deepen
the understanding of the role of modifiable risk factors in modulating disease incidence and severity and to
devising innovative means to translate findings to places of effective action. The AC will oversee a
comprehensive effort to build (C&T) research capacity by expanding and developing infrastructure, expertise,
and a workforce willing and able to address health disparities in our region. The AC will coordinate the
activities of all organizations and entities shown in Figure 1, including participating academic units, committees,
and boards. We also will marshal existing USC core resources and monitor and manage the CLINTRUSC
budget, prepare accurate and timely program and financial reports, and conduct annual performance
evaluations of Cores. CLINTRUSC leaders are strongly committed to ensuring that all research findings are
translated to places of public health and clinical need where they will be directly and immediately relevant to
our high-risk populations. This means that all interventions and other research aimed at reducing disease
incidence and severity and increasing disability-free survival. To achieve our goals and specific aims, are
committed to ensuring that the results emanating from CLINTRUSC will be designed for dissemination.